ESTROGEN AND ANDROGEN IN REGULATION OF OVARIAN ANDROGEN SECRETION

An hCG stimulaton test will be used to investigate ovarian androgen production in normal women and functional ovarian hyperandrogenism (FOH). Specific hypotheses to be tested are a) 17-hydroxylase/ 17-lyase activity in FOH is abnormally sensitive to hCG. b) estrogen or androgen will inhibit hCG-induced rises at 17-PROG and androgen less in FOH than in normal women.